Smartphone image analysis for real time adequacy assessment during kidney biopsy

SUMMARY. The goal of this project is to develop image analysis tools that can be deployed as a smartphone
application to aid in the real time assessment of biopsy adequacy during percutaneous renal biopsy (PRB)
procedures. PRB remains an essential tool for the diagnosis and treatment of patients with medical kidney
disease and involves obtaining a small needle core of tissue from the kidney with the use of a biopsy gun. A
biopsy is deemed “adequate” if sufficient renal cortical tissue is obtained to meet criteria for rendering a
histopathologic diagnosis. If insufficient tissue is obtained, or if the tissue does not contain renal cortex with
enough glomeruli, then the core is deemed “inadequate”. Over the last 15 years, the rate of kidney biopsies that
are inadequate for complete diagnosis due to insufficient tissue has risen to 15%, representing a significant drain
on the health care system as well as a direct risk to patients who must be re-biopsied or go without an accurate
diagnosis. Ideally, adequacy can be assessed at the time of biopsy by examination of the obtained cores under
a microscope by a pathologist. Such real time assessment enables the biopsy physician to obtain additional
cores of tissue if existing cores are deemed to be inadequate. However, resource constraints have markedly
limited the availability of adequacy evaluation within many biopsy suites. With the widespread adoption of
smartphones, there is now an opportunity to evaluate biopsy tissue via macro images instead of a microscope.
An additional step is to build image analysis capabilities into an application on the smartphone, thus enabling
the biopsy physician to obtain reliable instantaneous feedback about whether the material they have collected is
sufficient or whether the biopsy “missed”, and more tissue needs to be obtained. A recent study of 123,372 native
kidney biopsies found that the miss rate in PRB increased markedly from 2% in 2005 to 14% in 2020, largely
attributed to the increased involvement of radiologists performing the biopsies and their preference for smaller
diameter biopsy needles. This increase in kidney biopsy miss rate significantly impacts patient care in the
management of medical kidney disease and highlights the need for improved tools for assessing the
adequacy of tissue collected before the patient leaves the biopsy suite. In Phase I, Arkana Laboratories
will collaborate with the Kolachalama laboratory at Boston University using biopsy cores taken from unused
deceased donor kidneys to develop a deep neural network that can accurately classify which portions of a biopsy
core represent renal cortex vs non-cortex tissue, which may include renal medulla, perirenal fat, fibrous capsule,
and non-renal tissue. In Phase II, we will extend these efforts using images taken from kidney biopsies received
by Arkana to optimize the algorithmic assessment of adequacy and then use these results to develop a
professional version of the smartphone application that will be available to all kidney biopsy practitioners using
virtually any smartphone camera.

Public health relevance
PROJECT NARRATIVE. Kidney biopsy remains an essential tool for the diagnosis and treatment of patients with medical kidney disease and involves obtaining a small core of tissue from the kidney using a biopsy needle. Over the last 15 years, the rate of kidney biopsies that are deficient for diagnosis due to insufficient tissue has risen to 15%, representing a significant drain on the health care system as well as a direct risk to patients who must be re-biopsied or go without an accurate diagnosis. This project proposes to develop image analysis tools that can be deployed on smartphones to obtain high quality images of fresh biopsy tissue and determine whether the tissue is likely to be adequate for diagnosis, thereby informing the biopsy physician whether additional cores should be obtained and decreasing the patient’s risk of re-biopsy.